PRECHRONIC TOXICITY STUDIES OF CADMIUM OXIDE

The objective of this project is to develope, evaluate, and report the methodology and results for generation and monitoring techniques necessary for conducting prechronic inhalation studies with cadmium oxide.